Long-acting naltrexone for pre-release prisoners: A randomized trial of mobile treatment

Abstract
Disorders involving opioid use are a severe problem among jail and prison inmates. Inmates in the US,
Canada, Australia, and many European and Asian nations have disproportionately higher rates of opioid use
disorders than their general populations. Scarce resources are provided for corrections-based substance use
treatment in many nations, and many inmates with OUDs remain untreated. The use of long-acting, injectable
naltrexone (XR-NTX) may be a promising form of treatment for pre-release prisoners. Naltrexone blocks the
intoxicating and reinforcing effects of opioids, but has no opioid-like effects. This proposed five-year study will
focus on whether the addition of providing XR-NTX treatment at a patients’ place of residence will increase
adherence and thus efficacy of the medication. Project implementation will occur at five pre-release prisons
under the jurisdiction of the Maryland Department of Public Safety and Correctional Services (MDPSCS): 1)
Metropolitan Transition Center (MTC) for men; 2) Baltimore Pre-Release Unit (BPRU) for men; 3) Jessup Pre-
Release Unit (JPRU) for men; 4) Baltimore City Correctional Center (BCCC) and 5) Maryland Correctional
Institution (MCI) for Women. Following initial screening, informed consent, and medical examination, pre-
release prisoners at each facility will be block randomized (N=240) within gender to either: Condition 1. XR-
NTX-OTx (n=120): One injection of XR-NTX in prison, followed by six monthly injections post-release in the
community at an opioid treatment program; or Condition 2. XR-NTX+MMTx (n=120): One injection of XR-NTX
in prison, followed by six monthly injections post-release in the community at the patient’s place of residence.
All participants will be confirmed opiate-free by urine test and negative naloxone and oral naltrexone tests, and
evaluated monthly for seven months and 12 months after release from prison. The proposed study has two
specific aims: Aim1. To compare the two study conditions in terms of: a) XR-NTX treatment adherence; b)
opioid use; c) criminal activity; d) re-arrest; e) re-incarceration; and f) HIV risk-behaviors (i. needle use; ii. risky
sexual behaviors). Aim 2. To determine if the number of months of post-release XR-NTX treatment is related to
outcome (a-f above), and if so, is there a point at which XR-NTX v. Non-XR-NTX equilibrates? This would help
determine the number of injections, important because of XR-NTX cost. Many individuals in the criminal justice
system drop out of treatment and therefore increasing ways to improve adherence by attempting to: 1) expand
capacity; and 2) implement access by providing treatment at their place of residence may positively impact
outcomes.

Public health relevance
Project Narrative The proposed study is innovative because it would be the first randomized clinical trial in the US assessing effectiveness of receiving XR-NTX at an opioid treatment program vs. XR-NTX using mobile medical treatment. The public health impact of the proposed study will be highly significant and far-reaching because most individuals with OUD do not receive substance use treatment while incarcerated, thereby substantially raising their likelihood of re-addiction, overdose death, HIV/AIDS infection, and re-incarceration. Furthermore, many individuals in the criminal justice system drop out of treatment and therefore increasing ways to improve adherence by attempting to: 1) expand capacity; and 2) implement access by providing treatment at their place of residence may positively impact outcomes.